Multiracial Discrimination Scale: Development and Psychometric Validation of its Associations with Alcohol Use and Misuse among Multiracial Young Adults

Summary/Abstract
Young adulthood is a developmental epoch for alcohol misuse (defined as a pattern of drinking that increases
risks for adverse health outcomes). Multiracial (defined as having biological parents of two or more
racial/ethnic groups) young adults may be differentially vulnerable to alcohol misuse as they report both the
highest prevalence of past-year alcohol consumption and alcohol use disorder compared to other racial/ethnic
young adults. Multiracial discrimination is a racially relevant stressor for Multiracial young adults and may be
associated with alcohol-related disparities, as consistent with minority stress and tension reduction
frameworks, as well as robust support for the discrimination-alcohol misuse association in monoracial young
adults. However, our knowledge of Multiracial discrimination is fragmented and compounded by measurement
concerns. Notably, general discrimination scales are commonly used to assess Multiracial discrimination
despite research demonstrating general discrimination and Multiracial discrimination as distinct constructs.
Further, existing Multiracial discrimination scales lack specificity with the source of the discriminatory treatment
even though discriminatory messages vary by perpetrators and may be differentially associated with health
(including alcohol) outcomes. In the absence of a scale capturing the lived experience of Multiracial
discrimination among Multiracial people, alcohol researchers cannot resolve whether Multiracial discrimination
is a sociocultural determinant of alcohol misuse and contributing to alcohol-related disparities among
Multiracial young adults, who are driving substantial demographic change in the United States. Thus, using a
sequential mixed methods approach, the proposed project aims to (a) explore and generate a nuanced view of
Multiracial discrimination using thematic analysis from Multiracial young adult focus groups, (b) develop and (c)
psychometrically validate the Multiracial Discrimination Scale using exploratory and confirmatory factor
analyses, and (d) assess concurrent associations between Multiracial discrimination with alcohol misuse using
structural equational modeling. Findings of this project will provide alcohol researchers with a psychometrically
sound scale to characterize the scope and magnitude of the Multiracial discrimination-alcohol misuse pathway,
to potentially highlight an intervention point preceding alcohol misuse, and thus informing the culturally
sensitive design of evidence-based interventions implemented to reduce and prevent alcohol misuse among
Multiracial young adults. This NRSA Individual Predoctoral Fellowship to Promote Diversity in Health-Related
Research would provide specialized training in mixed methodologies (e.g., connecting qualitative/quantitative
data), psychometric statistics (e.g., test theory), and investigating latent constructs (e.g., structural equation
modeling), thus providing instrumental support for my developing research program, and laying out a path for a
long, prolific, NIH-funded alcohol research career.

Public health relevance
Project Narrative Multiracial discrimination may be driving alcohol-related risks and disparities among Multiracial young adults; however, fragmented knowledge about Multiracial discrimination and measurement concerns disallows alcohol researchers to test the Multiracial discrimination-alcohol misuse pathway. Using a sequential mixed methods approach, the proposed project will develop and psychometrically validate a Multiracial Discrimination Scale as informed by Multiracial young adults’ experiences of Multiracial discrimination, and test concurrent associations of Multiracial discrimination with alcohol misuse. The findings of this project will provide a psychometrically sound scale for alcohol researchers to investigate Multiracial discrimination as a sociocultural determinant of alcohol misuse, which in turn may further inform culturally sensitive intervention research to reduce and prevent alcohol misuse among Multiracial young adults.